Postbaccalaureate Research Education Program In Diabetes, Endocrinology and Metabolic Diseases (PRIDE)

PROJECT SUMMARY
Program Objectives and Goals: This R25 proposal, Postbaccalaureate Research Education Program in
Diabetes, Endocrinology, and Metabolic Diseases (PRIDE), aims to provide recent URM college graduates with
an intensive two-year mentored research experience in diabetes, endocrinology, and metabolism (DEM), and
tailored professional development coursework to successfully guide scholars through the graduate school
application process and ensure their success in completing a research-focused biomedical degree program
(Ph.D. or MD/PhD). Through our proposed recruitment efforts and multi-layered mentoring approach, this
proposal will build and enhance the diversity of the biomedical research workforce in NIDDK mission areas.
Program Design: PRIDE will be geared towards URM college graduates who have graduated no more than 36
months prior to the start of the program and are not currently enrolled in a degree program. Eight scholars in
total will participate in the WashU PRIDE program. In year 1, PRIDE will recruit four scholars for two years of
intensive training in biomedical DEM research and professional development by leveraging the robust physical,
administrative, and educational infrastructure and DEM resources available at WashU. In year 3, an additional
four scholars will be recruited to participate in the program. Our Program Directors (PDs) have an extensive
collaboration record in designing, organizing, and recruiting for DEM-related trainee programs. They lead highly
successful summer and year-round programs for undergraduate and graduate URM scholars at WashU to
support long-term research pathways into DEM. We will use evidence-based recruitment strategies and leverage
our strong relationships with institutions primarily serving URM students to recruit scholars into the program.
The Research Training Plan will include: 1) State-of the-art, structured, yet individualized research training by
performing DEM-related scientific projects; 2) Personalized selection of seminars, workshops and coursework
for scholars to develop skills necessary for acceptance and completion of top-tier doctoral degree programs and
expertise in DEM research and 3) Engagement with other WashU post-bac and graduate-level scholars.
To achieve these program goals, we propose the following aims: Aim 1. Integrate and augment current training
programs to fit the unique needs of PRIDE trainees. Aim 2. Recruit URM postgraduate scholars and provide
individualized mentorship for their successful entry and completion of a doctoral degree program. Aim 3. Provide
rigorous DEM-focused research, coursework, and networking opportunities for scholars using a competency
(rather than deficit) model. Aim 4. Evaluate the effectiveness and implementation of NIDDK-PRIDE. These
objectives will encourage and facilitate undergraduate students from URM groups to stay engaged in scientific
research and support their entry into graduate programs performing research related to NIDDK.

Public health relevance
PROJECT NARRATIVE This proposal will provide recent college graduates from under-represented minority groups with an intensive two-year mentored research experience in a laboratory that studies diabetes, endocrinology, and metabolism, and tailored professional development coursework to successfully guide them through the graduate school application process and ensure their success in completing a research-focused biomedical degree program (PhD or MD/PhD). Through our proposed recruitment efforts and multi-layered mentoring approach, this proposal will build and enhance the diversity of the biomedical research workforce in NIDDK mission areas.